Computational ontology of brain systems across the human neuroimaging literature

Project Summary/Abstract
Symptom-based diagnoses of mental illness are highly comorbid, biologically heterogeneous, and poorly
predictive of treatment response. The National Institute of Mental Health has led efforts to redefine mental
illness by its biological causes, establishing the Research Domain Criteria (RDoC) framework as a guide for
investigating variation in basic brain systems. RDoC has been influential, named in hundreds of grants and
publications, but it has yet to be systematically validated. It is unknown whether circuit-function links underlying
the RDoC brain systems are reproducible across studies, and organizing principles remain largely untested.
While the structure of RDoC as a modular hierarchy has evidence in resting state analyses, it has not been
shown whether this applies to systems that support the diverse mental states affected in psychiatric disease.
It is necessary to validate RDoC, and moreover, to establish fundamental principles of organization for
systems defined jointly by human brain structure and function. The objective of this proposal is to apply large-
scale computational neuroimaging meta-analyses to build a data-driven ontology that will not only serve as a
benchmark in evaluating the validity of RDoC but also characterize the architecture of systems for human brain
function. The long-term goal is to redefine mental illness by differences from healthy function within the brain
systems of a data-driven ontology, facilitating rational targeting of neuromodulation treatments.
The proposed meta-analyses will be the most comprehensive in the field with 18,155 MRI and PET studies
already collected. The mental functions considered in these studies have been extracted from article texts
using natural language processing, and brain circuits will be mapped from the brain coordinate data that were
reported. The hypothesis is that brain systems are comprised of reproducible circuit-function links organized
into a modular hierarchy, which for some systems will require updates to RDoC. This will be tested by
comparing RDoC systems against those of a data-driven ontology. Aim 1: The reproducibility of circuit-function
links will be evaluated by the performance of neural network classifiers predicting functions in article texts from
circuits in brain scan data, and vice versa. Aim 2: The modularity of brain systems will be evaluated by a graph
theoretic approach, and hierarchical structure will be assessed by representational similarity analysis.
The impact of this project will be to validate the foremost psychiatry research framework and to characterize
human brain systems through an innovative computational strategy. Together with targeted academic training
in neurobiology, the fellowship is designed to offer preparation for a career as a physician-scientist leading
advances in computational psychiatry. Training will be supported by an environment that combines world-class
computing resources with esteemed and engaged mentors in psychiatry, neuroscience, and computer science.

Public health relevance
Project Narrative First-line treatments routinely fail for most of the 45 million US adults living with mental illness because psychiatric diagnoses lack a biological basis, making them unreliable predictors of treatment response. The proposed project will lay the foundation for a biologically based diagnostic system in psychiatry by characterizing the composition and structure of human brain systems through innovative computational meta-analyses of nearly 20,000 neuroimaging articles. When it is understood what makes up a brain system and how systems are organized, mental illness can be redefined by variation from healthy function, facilitating successful targeting of brain-based treatments.